PRAISE 2--EFFECT OF AMLODIPINE ON SURVIVAL IN PTS W/ CHF

The study is being done in order to determine the effects of an investigational drug, amlodipine, on survival in patients with moderate to severe heart failure.